Generation of human skin organoids from pluripotency (Admin Supplement)

ABSTRACT
Skin morphogenesis and homeostasis necessitate the assembly of diverse cells originating from different
embryonic tissues, which poses a considerable engineering challenge when aiming to construct complex and
easily assembled skin in vitro. Such constructs could have significant applications, including cell therapy for burn
and wound treatment. The specific issue lies in the commonly used cells for in vitro skin derivation; they lack the
capacity to form skin appendages, such as hair follicles and sweat glands, and accessory cells, like melanocytes
and adipocytes. Therefore, identifying the pivotal cell signaling mechanisms required to differentiate appendage-
bearing skin from progenitor cells, like human pluripotent stem cells (hPSCs), or to stimulate skin appendage
induction from adult skin cells, represents a critical barrier to progress. While we can efficiently generate
epidermal cells from hPSCs in vitro, the regulation of dermal progenitor cell induction and other components of
the skin microenvironment remains uncertain. As such, our long-term objective is to ascertain the chemical and
physical signals necessary to recapitulate the development of human skin progenitor cells and reconstitute
complex skin. This supplementary project builds upon the progress made in our parent project, "Generation of
human skin organoids from pluripotency," by introducing a new aim focused on modeling pain pathways in skin
organoids. Firstly, we will test the hypothesis that nociceptive neurons emerge in skin organoids and form
specialized nerve endings associated with terminal Schwann cells, akin to human fetal and newborn skin.
Additionally, we aim to establish a methodology for generating stereotyped nociceptive innervation of skin
organoids grown in a tissue-chip environment for accessible live-cell imaging. Secondly, we will examine the
hypothesis that macrophages co-derived in skin organoids can modulate the functional activity of nociceptors,
thereby mimicking cell-cell interactions implicated in pain initiation and resolution. Successful completion of these
aims will provide preliminary data for innovative new imaging-based investigations into the mechanisms of acute
and chronic pain and inflammation in the skin. In alignment with the parent award, we also expect to gain
considerable insight into the earliest stages of human skin and pain circuit development for researchers studying
skin organogenesis. Furthermore, our efforts may inform strategies for resolving pain associated with conditions
that require tissue reconstruction using skin organoid-derived cells.

Public health relevance
PROJECT NARRATIVE During embryonic development, the formation of skin tissue involves complex interactions between cell sheets, connective tissue cells, fat, and nerve cells. To gain a detailed understanding of how these cells form in the embryo, we will investigate a new approach to direct human stem cells to build skin with pigmented hair, fat, and nerves in a culture dish. This supplementary project will focus on deriving and evaluating the function of pain sensing neurons in our stem cell-derived skin cultures to create a new model for pain research.